Physiology of Lifespan Extension and Metabolic Hormesis with Riboflavin Depletion

This proposal describes a five-year plan for Armen Yerevanian MD to transition to an independently-funded
investigator with expertise in the metabolism of aging and the molecular physiology of riboflavin. He will be
mentored by Alexander Soukas MD PhD, Associate Professor of Medicine at Harvard Medical School and an
expert in both functional genomics and the biology of C. elegans. He will be co-mentored by Marcia Haigis PhD,
Professor of Cell Biology at Harvard Medical School and a member of the Paul F. Glenn Center for the Biology
of Aging. An advisory committee of physician-scientists with expertise in human aging, C. elegans aging, and
metabolism have been assembled, including Gary Ruvkun PhD, Keith Blackwell MD PhD, Jose Florez MD PhD,
and Richard Lee MD to provide scientific direction and career guidance during the transition to independence.
Dr. Yerevanian will carry out the planned career development activities in the research and training environment
at the Massachusetts General Hospital and Harvard Medical School.
This research program utilizes the organism C. elegans, murine cell lines and mouse models to examine the
physiology of riboflavin depletion and identify the core molecular mechanisms that underpin the lifespan
extending effects of riboflavin depletion in C. elegans. The biology of riboflavin utilization and transport is strongly
conserved through metazoans, making it an attractive area to study as a translational target. The ability to
modulate cellular energetics and metabolic hormesis through riboflavin depletion may provide key therapeutic
targets for the complications of aging, particularly metabolic complications including insulin resistance, changes
in body composition and neurodegenerative diseases. Preliminary studies have already shown that riboflavin
depletion extends lifespan in C. elegans, and utilizes canonical pathways associated with longevity including
AMPK and FOXO. We hope to further elucidate the metabolic regulators of this process, including flavin co-
factor synthesis, mitochondrial energetics, and lipid metabolism. The investigator will utilize functional genomics
of C. elegans, metabolic assays of enzyme regulation, and novel mechanisms for altering cellular energetics to
explore these aims. The ultimate goal of this work is to characterize the fundamental biology of riboflavin
depletion, promote metabolic hormesis and healthy aging via riboflavin depletion in translational models, and to
transition to independent investigator status.

Public health relevance
Calorie restriction has been shown to be beneficial to healthspan and lifespan in multiple animal models. We have shown that depletion of riboflavin, also known as Vitamin B2, extends lifespan in the nematode worm in a model similar to calorie restriction. This project serves to investigate the mechanisms of how this occurs and whether riboflavin depletion can promote similar benefits in mammals, with the hope of identifying new treatments for aging associated diseases.